Mentorship Education to Advance Biomedical Research Career Development

PROJECT SUMMARY
Mentorship plays a critical role in the preparation of early career scientists navigating their careers, an
essential step toward building a strong and sustainable biomedical research workforce. This proposal brings
together Professional Development Hub (pd|hub) and the Center for the Improvement of Mentored
Experiences in Research (CIMER) to develop evidence-based curricula and resources to support career-
related mentoring conversations in research environments. We propose an approach that is community-driven,
with research advisors (supervisory mentors), students/postdocs (mentees), educators, and scholars of career
decision-making coming together into a Mentorship Action Collaborative at various entry points to (a) identify
priority competencies that should be addressed to enhance career-related mentorship, (b) highlight local
resources already being developed in this area, (c) join advisory development teams to inform resources and
curricula as they are developed, and (d) be early adopters beta-testing resources and curricula.
This project is innovative in its (1) development of novel curricula and resources for research advisors and
mentees to enhance evidence-based practices in career-related mentorship, (2) engagement of diverse
stakeholders critical to graduate student and postdoc career development through structured communities of
transformation, (3) design of assessment instruments to evaluate career development support through
mentoring relationships, and (4) building of synergy between mentorship and other supports to maximize
mentee outcomes. Using best practices of dissemination and implementation, we will catalyze dissemination
across our broad and widespread networks. This comprehensive plan to enhance training will enable graduate
students and postdoctoral scholars to adapt, succeed, and thrive in a strong and diverse biomedical research
workforce.

Public health relevance
Project Narrative Mentorship plays an important role in the preparation of early career scientists for their careers, but there are barriers and challenges common in navigating career-related discussions with research mentors that has led to a deficit in the educational experience of doctoral students and postdocs across biomedical research disciplines. This project will enhance mentorship practices by developing and catalyzing the widespread adoption of centralized evidence-based curricula and resources for supervisor-mentee career-related mentoring conversations. By bringing faculty, mentees, staff/administrators, scholars, and national leaders together to inform development of mentorship education resources and curricula, we will build synergistic bridges within the training ecosystem to support training a robust, diverse biomedical research workforce.